Mechanisms underlying the impact of dialect mismatch on spoken language comprehension

Project Summary/Abstract
Spoken language comprehension requires the integration of linguistic information with communicative
intent and sociocultural information (speaker identity). This process usually unfolds with relative ease but can
be disrupted by variability in the speech signal (e.g., background noise) and sociocultural differences (e.g.,
speaker race). It is these kinds of disruptions that characterize the challenges faced by students who speak
African American English (AAE) at home, but have to comprehend General American English (GAE) at school.
Students who speak AAE at home experience dialect mismatch, the presence of linguistic differences between
AAE and the dialect of instruction, which is almost always GAE. Dialect mismatch has been shown to
negatively impact spoken language comprehension, but the mechanisms that underlie this relationship remain
unclear. These consequences have been traditionally explained in terms of signal degradation, in which
perceptual analysis is more difficult (perceptual costs hypothesis). However, spoken language
comprehension is more than perceptual analysis. An alternative explanation, the epistemic trust hypothesis
posits that the effects of dialect mismatch on spoken language comprehension also arise from sociocultural
differences between conversational partners. The primary objective of this research is to evaluate the validity
of the epistemic trust hypothesis.
Using the visual world paradigm, the effects of dialect mismatch and group membership on the
comprehension of literal and intending meaning will be evaluated in 7- to 9-year-old children learning AAE or
GAE. To evaluate the effects of dialect mismatch on spoken language comprehension, children will hear
sentences in a familiar and unfamiliar dialect of English. To evaluate the role of epistemic trust, sentences will
be paired with visual images of speakers of different races to convey in-group or out-group membership. Aim
1 examines the effect of dialect and group membership on semantic prediction. Aim 2 examines the effect of
dialect and group membership on children’s pragmatic inferencing skills, specifically, scalar implicatures.
Collectively, these two studies innovatively respond to the question of how dialect mismatch impacts
spoken language comprehension. Traditional explanations focus on perceptual costs, which has resulted in the
development of dialect-shifting curricula. However, spoken language comprehension is more than perceptual
analysis and requires integration of speaker intent, which may be harder to do when there are both dialect and
sociocultural differences. The studies proposed directly test the validity of the epistemic trust hypothesis. If this
hypothesis is supported, then this would suggest that curricula that also consider epistemic trust may be better
suited to address educational consequences associated with dialect mismatch.

Public health relevance
Project Narrative Negative effects of dialect mismatch on spoken language comprehension potentially arise from two sources: perceptual discrepancies in the linguistic signal (perceptual costs) and sociocultural differences between conversational partners (epistemic trust). Isolating effects of dialect mismatch that emerge from sociocultural differences will improve our understanding of the mechanisms that underlie the negative consequences of dialect mismatch on spoken language comprehension. The knowledge gained from these experiments will help to develop evidenced-based curricula to support students who speak nonmainstream dialects of English at home.